Transition Metal-Catalyzed Alkene Functionalization

Project Summary
After carbon and hydrogen; oxygen, nitrogen, and fluorine are the three most common elements found in
pharmaceuticals and drug candidates. Lead identification and optimization is typically the longest part of the drug
discovery process, taking about five out of the average fifteen years, to bring a drug to market. This is partially
due to the requirement to synthesize and test of a large number of potential drug candidates through structure
activity relationship (SAR) studies. As such, the development of new organic methodologies for the rapid
synthesis of organic molecules is of utmost importance to synthetic chemists. The research described herein
focuses on the development of novel approaches for the synthesis of C–N, C–O, C–S, C–P, C–F, C–Cl, C–Br,
and C–B bonds, in a selective and expedient manner. Moreover, it seeks to allow for divergent synthesis; where
from a single common intermediate libraries of potential pharmaceuticals could be synthesized in a single
synthetic transformation simply by varying the reagents. More specifically, the proposal focuses on the
development of an array of carbon-carbon double bond difunctionalization of using a copper or palladium
catalyst.

Public health relevance
Project Narrative The transition-metal-catalyzed alkene difunctionalization reactions for the formation of two C–functional group bonds (C, N, O, S, P, Br, Cl, F, or B) in a single transformation is developed. The work focuses on expanding the diversity of the reactions, with a focus on regio-, chemo-, and stereoselective functionalization.